RESEARCH AND APPLICATION IN TEAM SCIENCE: A CONSENSUS STUDY

RESEARCH AND APPLICATION IN TEAM SCIENCE: A CONSENSUS STUDY - FY23 funds are provided to support the project, Research and Application in Team Science: A Consensus Study, through the NIH National Academy of Sciences contract.